Training Leaders to Prevent and Reduce Domestic Violence in Their Communities: Experimental Evidence From Peru

Abstract
Gender-based violence (GBV) affects one out of three women in the world, with long-term welfare consequences
for victims and families, and indirect costs to the health sector, the legal system, and the economy. Yet there
has been little rigorous research on the efficacy of interventions that aim to reduce or prevent GBV. As a result,
policymaking has been guided by “best-practice” manuals and little robust evidence. An emerging consensus
centers on multi-level and gender transformative approaches, but there is a lack of systematic research on the
effectiveness of this approach or insight into key components of programming. The goal of this project is to
deliver new rigorous evidence to the scientific and policy community by experimentally evaluating the impact of
alternative versions of a state-run GBV intervention in Peru. Our evaluation will provide evidence on the
effectiveness of distinct program components, assess their cost-effectiveness and potential to scale, and shed
light on mechanisms underlying changes in GBV. This project takes advantage of a long-standing partnership
with the Peruvian Ministry of Women (MOW) to conduct an experimental evaluation randomized across 250
villages of Leaders in Action (LIA), the MOW’s flagship GBV program that trains local leaders on gender violence
and norms. We experimentally assess the impact of its two main components: a household-based module (HT),
consisting of household visits by trained leaders, and a group-based module (GT) with education sessions in
small gender-segregated groups organized by trained facilitators. We will cross-randomize each approach to
assess their efficiency in reducing domestic violence and changing social norms around tolerance toward
violence and gender roles. The study disentangles the impact of the two modules separately, as well as their
interaction, while explicitly addressing methodological concerns of previous studies. Reporting bias from self-
reported measures will be addressed with a fully private self-administrated instrument, and a large clustered
sample will address statistical power limitations of previous studies. In addition, comprehensive male and female
survey instruments are designed to shed light on the potential mechanisms and theoretical framework underlying
GBV. Finally, our experimental design will allow us to disentangle short and long-term effects, and the efficacy
of separate delivery modes. This is a unique opportunity to evaluate government programs to guide GBV
programming in Peru and worldwide, estimate their cost effectiveness, and bring scientific evidence on GBV
reduction and prevention. The MOW is eager to incorporate the results to its programming of the Peruvian
National Plan Against GBV. The project includes policy outreach activities to guide MOW’s policymaking through
workshops, policy briefs and capacity building sessions. We expect future research to address the accuracy of
extrapolating our findings to other Latin American countries and contrast them to experiences in Africa and Asia.

Public health relevance
Project Narrative Despite affecting one out of three women worldwide, to date there has been little rigorous research on the efficacy of large-scale interventions to reduce and prevent GBV. The proposed study evaluates the impact of a novel policy intervention in rural Peru aimed at reducing GBV and changing social norms, and compares the relative efficacy of two standard approaches to GBV programming: i) a home-based approach in which facilitators visit households to increase awareness of GBV, and ii) a group-based approach, in which facilitators organize gender-segregated group sessions in communities to discuss domestic violence and masculinity using media dramatizations of social problems. The study disentangles the short- and long-term effects of each treatment separately, as well as their interaction, on incidence and awareness of GBV, mental health, social norms regarding gender roles and GBV, agency, empowerment, attitudes and behaviors.